AANP Scholars' Workshop on Neurodegenerative Disease Neuropathology Research

Project Summary/Abstract
This R13 grant application is to support a pre-meeting career development workshop to be held prior to
the Annual Meeting of the American Association of Neuropathologists (AANP). The National Plan to Address
Alzheimer’s Disease calls for the prevention and treatment of Alzheimer’s disease and related dementias
(ADRD) by 2025. Critical to this goal is maintaining, developing, and supporting neuropathology trainees to fill
the dearth of academic neuropathologists dedicated to ADRD and aging research. Towards this end, the annual
AANP meeting represents a national focal point for neuropathology trainees. The first AANP Scholars’
Workshop was held in June 2020 and has been remarkably successful in guiding neuropathology trainees
towards an academic neuropathology career. This R13 grant will fund the AANP Scholar’s Program which is a
career development and scientific pre-meeting workshop for a cohort of 75 neuropathology trainees over five
years. Workshop themes will alternate every other year between “Expectations and Barriers to an Academic
Neuropathology Career” and “Navigating Academic Neuropathology: Positions & Grants.” This workshop will
attract the most promising neuropathology trainees towards a career focused on ADRD by offsetting travel and
registration costs. This R13 grant will also support trainee travels awards to attend the Annual AANP Meeting
with a focus on supporting women and underrepresented minorities. The long-term impact of this meeting will
be to maintain a healthy pipeline of neuropathology trainees dedicated to ADRD research in support of the
national plan to prevent and treat ADRD.

Public health relevance
Project Narrative There is a national mandate to cure or prevent Alzheimer’s disease and related dementias by 2025, a task which will require the education and supporting of neuropathology trainees interested in academic research careers. This R13 application is to support a pre-meeting workshop for neuropathology trainees at the Annual Meeting of the American Association of Neuropathologists (AANP).